Improving fathers' mental health, parenting, and familial engagement through an mHealth intervention in Kenya

Fathers play a pivotal role in early child health and development with impact on mental, social, and financial
wellbeing throughout a child’s lifespan. One in ten fathers experience severe mental health challenges due to
the stressors of parenting. Fathers’ poor mental health adversely impacts their relationships with partners,
parenting behaviors and families’ health and safety, yet mental health services for fathers are scarce. The
adverse effects of low paternal involvement disproportionately affects low- and middle-income countries
(LMICs) of Africa where a quarter of ≤5 year-olds are developmentally delayed. WHO’s “Nurturing Care
Framework” prioritizes fathers’ parenting role and calls for strategies to improve dyadic father-child mental
health. Parenting interventions that support effective parenting knowledge, skills, and behaviors improve
parent-child mental health outcomes, including in LMICs. Involving fathers strengthens and extends positive
outcomes. Yet, most parenting programs solely engage mothers and prioritize mothers’ roles. Improving
fathers’ mental health and parenting skills requires interventions tailored to fathers’ unique roles, needs, and
preferences. Stigma and logistical challenges are reported by men in LMICs as barriers to in-person counseling.
Mobile health (mHealth) interventions increase confidentiality and convenience to address these barriers. mHealth
parenting interventions are acceptable and feasible in LMICs with benefits similar to in-person programs. To
date, no mHealth tools tailored to fathers’ mental health are developed for LMICs. We propose using the IDEAS
framework to develop “BABAText”—a father-facing mHealth parenting intervention to improve father-child
mental health tailored to the needs and preferences of Kenyan fathers. The proposed project leverages our
team’s ongoing study (R01HD100201, PrIMA-X) and extends novel data collection to adapt an existing
mHealth platform (Mobile WACh) which sends automated theory-based SMS messages and enables 2-way
communication with a remote nurse-counselor. In Aim 1, we will identify mental health needs, parenting
challenges, and preferences for mHealth approaches among Kenyan fathers in a mixed methods needs
assessment. In Aim 2, we will collaboratively develop “BABAText”, an mHealth parenting intervention for fathers,
using a user-centered approach by incorporating fathers’ needs and preferences, feedback from iterative
codesign workshops, and effective elements from evidence-based parenting and mental health interventions. In
Aim 3, we will evaluate the acceptability, preliminary efficacy, and implementation barriers and facilitators of
BABAText. This program of research will be conducted in partnership with fathers in Kenya to maximize impact.
Overall, I anticipate a mHealth parenting intervention co-developed with fathers will improve father-child mental
health and family wellbeing. This proposal addresses the high mental health burden among men in settings of
Africa and is designed to provide an acceptable, effective mHealth parenting support intervention for fathers.

Public health relevance
PROJECT NARRATIVE One in ten fathers experience severe mental health challenges due to the stressors of parenting and fathers’ mental health plays a pivotal role in early child social-emotional development with impact throughout a child’s lifespan. Parenting interventions that support effective parenting knowledge, skills, and behaviors improve parent-child mental health outcomes, including in low- and middle-income settings, yet in-person mental health services for men are scarce and are stigmatizing and logistically challenging for fathers to attend. We propose to develop and pilot test a novel mHealth parenting intervention specifically designed for fathers which incorporates fathers’ needs and preferences from a mixed methods needs assessment, interactive input from a stakeholder advisory group, and elements from evidence-based mental health and parenting interventions through a user-centered co-design approach with fathers in Kenya.